Modeling Progressive Familial Intrahepatic Cholestasis Type I Caused by ATP8B1 deficiency

PROJECT SUMMARY/ABSTRACT
ATP8B1/FIC1 belongs to the P4 subfamily of P-type adenosine triphosphatases. In the liver, it is localized
on the bile canalicular membrane to maintain its lipid asymmetry that is essential for proper function of the bile
salt transporters. In humans, mutations in ATP8B1 result in rare forms of chronic intrahepatic cholestasis with
autosomal recessive inheritance. The most severe form of ATP8B1 deficiency, progressive familial intrahepatic
cholestasis type I (PFIC1), is characterized by normal serum GGT cholestasis and pruritus in early childhood
that can progress into end-stage liver disease. Due to the limitations of existing experimental models, ATP8B1
is understudied and our understanding of how ATP8B1 deficiency results in cholestasis remains incomplete,
precluding the development of effective therapy for PFIC1. Our long-term goal is to understand the etiology of
chronic intrahepatic cholestasis and improve patient diagnosis and treatment. The overall objective for this ap-
plication is to establish a novel zebrafish model for ATP8B1 deficiency to better understand the pathogenesis
of cholestasis and discover new therapeutic strategies. Our preliminary study demonstrated that Atp8b1-
deficient zebrafish developed cholestasis and were lethal by 2 weeks of age, providing proof of concept that
zebrafish can be used to model PFIC1. In this application, we propose to conduct further phenotypic analysis
of atp8b1 germline mutant zebrafish and develop assays to study ATP8B1 function in vivo. We will determine
the feasibility of using zebrafish to validate patient variants and test the effect of pharmaceutical intervention on
cholestasis. The rationale is that developing additional animal models of ATP8B1 deficiency will complement
the existing in vitro and rodent models and bring new knowledge into our understanding of ATP8B1 function
and the mechanisms of cholestasis caused by ATP8B1 deficiency. In Aim 1, we will characterize the cholestat-
ic phenotypes caused by Atp8b1 deficiency in zebrafish. We will track the subcellular distribution of fluorescent
lipids in the liver and intestine of wildtype and atp8b1 mutant larvae to understand how ATP8B1 regulates the
transport of lipids in vivo. In Aim 2, we will determine the feasibility of using zebrafish to validate the biological
function of ATP8B1 patient variants. We will introduce two common ATP8B1 missense variants into zebrafish
and determine if they change ATP8B1 expression and cause cholestasis. We will test if treatment with 4-
phenylbutyric acid rescues these animals. The research proposed in this application is highly innovative be-
cause it establishes a novel zebrafish model of ATP8B1 deficiency that offers unique advantages for studying
bile homeostasis and cholestatic phenotypes. We will also develop a pipeline for future drug screen to identify
compounds that rescue cholestasis caused by ATP8B1 deficiency. The study is also significant because this
new in vivo model is expected to advance our understanding of ATP8B1 function in bile homeostasis and
pathogenesis of PFIC1. The results from the study will provide critical preliminary data for a highly competitive
R01 application to further pursue disease mechanisms and drug discovery.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it establishes a new experimental model for studying ATP8B1 deficiency, which is expected to inform new therapies for neonatal cholestasis. The proposed research is relevant to the part of NIH's mission that pertains to seeking fundamental knowledge that will enhance health, lengthen life, and reduce illness and disability.